Core D: Next-Gen Sequencing and Bioinformatics

CORE D - NEXT-GEN SEQUENCING AND BIOINFORMATICS
PROJECT SUMMARY
Core D offers world-class genomics and bioinformatics services to the members of the Program. The Next
Generation sequencing facility was strongly supported by CSHL during the last five years, and it has extended
its capability in short (Illumina HiSeq2500, MiSeq and NextSeq) and long read technologies (Pacific Biosciences,
Oxford Nanopore). Core D offers an extensive array of sequencing applications, including but not limited to RNA-
Seq, Iso-Seq, whole genome sequencing, targeted sequencing (exomes, gene set, and amplicons), ChIP-Seq,
ChIRP-seq, and single-cell sequencing. Core D will also provide a wide array of bioinformatic services, which
includes the continued development of novel adaptations of STAR for defining the transcriptome of cancer cells.
A key focus of these innovations will be to map splicing patterns for investigation of ASO-mediated perturbations.
The Core will continue working with members to develop new sequencing and computational applications,
including in the area of long sequencing reads and single-cell sequencing, The Core will also offer experimental
design support, sequencing project management and sequencing QC analysis to the investigators.

Public health relevance
CORE D - NEXT-GEN SEQUENCING AND BIOINFORMATICS PROJECT NARRATIVE Genomics and Bioinformatics are essential tools in cancer research. Core D provides services in high-throughput sequencing and bioinformatic analysis to identify changes in transcription, splicing, and chromatin that drive the growth and maintenance of cancer. Bioinformatic tools will be continuously developed by this Core to support the evolving needs of the Projects.